Health Policy Training Program

DESCRIPTION (provided by the applicant): This grant seeks monies over a five-year period to support nine predoctoral students per year in the Harvard University Health Policy PhD training program, a program whose goal is to train investigators in health policy and health services research, consistent with the mission of AHRQ. Our students have written dissertations on topics related to quality and patient safety, disparities, and evaluating organizational and payment interventions. The PhD program is a collaboration among six Harvard faculties and is administered by a 45 member faculty committee that is appointed by the Dean of the Faculty of Arts and Sciences;the Committee is chaired by Joseph Newhouse, the Program Director for this grant. We have had our current training grant since 1994 and over that time have had 69 students as AHRQ trainees. We have attracted a high quality admissions pool and have many qualified persons who could be trainees;we have always filled our training grant slots. Our trainees have taken jobs in academia, research institutions, and government and generally have had multiple job offers. Several have won awards for their predoctoral research, including the last two AcademyHealth dissertation awards. Because of intensive monitoring and advising, most of our students finish their degree in six years or less. Of the 166 students who have ever begun the PhD program, 99 have graduated and 61 are currently enrolled. Our philosophy is that the students will work as part of an interdisciplinary research team and therefore need a discipline that they bring to the team as well as an understanding of the disciplines of other team members or potential readers of their work. To implement this philosophy the students choose one of seven disciplines in which they take about half their course work;additionally they take some course work in three other disciplines. We have a faculty member in charge of minority recruiting and have for the past several years consistently attracted qualified minority students.